Role of KCNQ2 Channels in Control of Breathing

SUMMARY
Developmental and epileptic encephalopathy associated with KCNQ2 channels has been primarily linked to
loss-of-function KCNQ2 mutations. However, an increasing number of recurrent KCNQ2 gain-of-function
variants (i.e., R201C) have been identified. Patients with the KCNQ2R201C mutation display severe myoclonus
and early profound hypoventilation due to reduced chemoreflex. Currently, mechanisms by which KCNQ2
channels control the drive to breathe are unclear. The retrotrapezoid nucleus (RTN) is an important respiratory
center; neurons in this region function as respiratory chemoreceptors by regulating breathing in response to
changes in tissue CO2. Chemosensitive RTN neurons are activated by an increase in CO2/H+, whereas a gain-
of-function Kcnq2 mutation might hyperpolarize RTN neurons and make it more difficult to respond to CO2/H+.
Indeed, work from the parent grant showed that expression of the recurrent Kcnq2 mutation Kcnq2R201C in RTN
neurons blunted the ventilatory response to CO2. Excitingly, we also found that Kcnq2 channel activity in RTN
neurons is regulated by a H+-myo-inositol cotransporter (HMIT) which imports myo-inositol to support
production of phosphatidylinositol 4,5-bisphosphate (PIP2), an allosteric activator of Kcnq2 channels. HMIT
expression in the RTN region is restricted only to chemosensitive neurons. Therefore, we hypothesize that
HMIT is required for Kcnq2 channel activity in RTN neurons. In particular, we propose that H+-dependent myo-
inositol transport into RTN neurons by HMIT will increase PIP2 levels and activate Kcnq2 channels to limit
CO2/H+-stimulated activity, as well as to maintain neural modulation by neurotransmitters that signal through
Gq-coupled receptors and PIP2 hydrolysis. Thus, the objective of this application is to determine the extent to
which Kcnq2 channels and HMIT interact to control RTN chemoreception under normal conditions and whether
HMIT can be targeted to improve breathing in mice that express Kcnq2R201C. The three Specific Aims of this
project are: 1) determine the extent to which HMIT influences Kcnq2 channel regulation of chemosensitive
RTN neurons; 2) determine contributions of Kcnq2 channels and HMIT interactions to RTN chemoreceptor
network excitability; and 3) to establish HMIT in RTN neurons as a therapeutic target for Kcnq2 associated
breathing abnormalities. The rationale for this research is that by understanding how HMIT regulates Kcnq2
channel activity in RTN neurons, we can lay a foundation for developing treatments for respiratory problems
associated with Kcnq2 mutations.

Public health relevance
Project Narrative In the past several years, important progress has been made in identifying genes implicated in neurodevelopmental disorders. It is now recognized that KCNQ2 loss and gain of function mutations lead to developmental epileptic encephalopathy that might also include respiratory dysfunction and severe central hypoventilation syndrome. Therefore, the goal of this application is to understand the essential role of KCNQ2 in control of breathing that may explain both the origins and developmental progression of symptoms, as well as to propose strategies for effective therapeutic interventions.